Kansas Center for Implementation Science: Pragmatic Implementation Science Methods (PrISM) Core

PROJECT SUMMARY/ABSTRACT: PRAGMATIC IMPLEMENTATION SCIENCE METHODS (PrISM) CORE
Regardless of their research training or inherent talent, the learning curve for new investigators in implementation science can be steep. The Pragmatic Implementation Science Methods (PrISM) Core will provide COBRE and other KUMC investigators the coordinated, interdisciplinary support that is critical to success in this complex field. The PrISM Core’s ‘team science’ approach will increase the likelihood of successful execution of research projects and better prepare Research Project Leaders for working in the collaborative research environment that is critical to implementation science.
Aim 1. Establish an implementation science methods core bringing together expertise in implementation science theory and methods and leveraging the principles of team science to seamlessly integrate expertise in biostatistics, medical informatics, mixed methods research, and health care research. The PrISM Core will work closely with the Community Engagement and Outreach Core to provide researchers with access to research sites and clinical data needed to support pragmatic implementation research that advances the quality of health care.
Aim 2. Support Research Project Leaders in project conceptualization, design, execution, and analysis, and plans for future research. We will use an adaptation of Proctor’s classic model of implementation research to create a framework for supporting Research Project Leaders through each step of implementation research, including: describing existing gaps in health care, developing implementation strategies, analyzing outcomes, reporting results, and designing new, innovative research proposals to extend or disseminate findings from COBRE-supported work.
Aim 3. Foster new applications and implementation science methods to improve health outcomes. The PrISM Core will work with the Administrative Core to support investigators and advance implementation science methods, including methods that address unique issues in rural communities. The PrISM Core will also continually scan the field to identify critical gaps in implementation research in order to help prioritize COBRE efforts.
Aim 4. Collaborate with the Administrative Core to evaluate PrISM Core effectiveness. The PrISM Core addresses a previously unmet need at KUMC for an integrated team focused on implementation science. The PrISM Core will increase institutional and regional capacity to conduct high quality implementation research, will make research projects more pragmatic, and as a result will increase the Kansas Center for Implementation Science’s potential for sustained and widespread impact on the field.